Plan to Enhance Diversity

PLAN TO ENHANCE DIVERSITY: PROJECT SUMMARY
Georgetown Lombardi Comprehensive Cancer Center’s (LCCC) Diversity, Equity, and Inclusion (DEI) Plan aims
to evaluate, develop, and implement strategies to enhance and promote equitable participation, inclusion, and
leadership of individuals from backgrounds underrepresented in cancer research. The overall vision of the LCCC
DEI Plan is to create and sustain diversity within a culture of equity and inclusive excellence. LCCC will
implement and evaluate strategies to (1) increase diversity of trainees, Members, and the research workforce,
(2) enhance equitable participation, and (3) promote inclusion and leadership by individuals from backgrounds
underrepresented in research. LCCC DEI builds on a strong history of attention to social justice and diversity,
equity, and inclusion within Georgetown University (GU) and has aligned the DEI specific aims with values held
across the Consortium. Guided by The Foundational Principles of Inclusive Excellence framework from the
Association of American Medical Colleges, the LCCC DEI goals will be accomplished through three specific
aims. Aim 1: Collect and evaluate diversity metrics and improve infrastructure to recruit, retain, and track trainees
and Members from groups underrepresented in science and cancer research. DEI has established and will
continue to track metrics and support recruitment of diverse Members and trainees with ongoing input from the
LCCC DEI Advisory Council. The DEI Office will collaborate closely with the Cancer Research Training and
Education Coordination (CRTEC) Office for tracking metrics, including demographics (gender, race, ethnicity,
ability), among trainees and Members participating in cancer research. DEI has reviewed and implemented best
practices and policies for recruitment and equity in the hiring of women and individuals underrepresented in
cancer research. Aim 2: Foster a culture of inclusion and active participation in cancer research for women and
individuals from groups underrepresented in research to retain talent and advance professional careers for all.
Activities at the undergraduate and graduate levels will be conducted in collaboration with CRTEC, Community
Outreach and Engagement (COE), GU, MedStar Health, and John Theurer Cancer Center/Hackensack Meridian
Health (JTCC/HMH) through fellowship programs focused on cancer research. Among Members, activities will
support professional development and foster a sense of inclusion through peer groups, pilot research support,
and seed funding focused on diversity, equity, and anti-racism. DEI will recognize efforts through annual awards
for Members, staff, and students. Aim 3: Support intentional leadership development and advancement by
women and individuals underrepresented in research. LCCC’s DEI will identify and provide opportunities that
promote leadership development, including leadership training and professional coaching open to LCCC
Members across rank and track. DEI will provide professional development to current leaders in terms of
expanding inclusive leadership practices and sustaining an inclusive culture.